Effects of Dietary Patterns and Sodium Intake on the Gut Microbiome and Metabolome

PROJECT SUMMARY
Research on the gut microbiome as a target for disease prevention and therapy is an intriguing arena for public
health because microbes and their metabolites are modifiable. Observational studies, murine models and a
few trials in humans suggest dietary factors exert many of their health effects in the host through modification
of the gut microbiome and its associated metabolome. Moreover, early evidence indicates the microbiome and
metabolome modify the effects of diet interventions on health outcomes, suggesting the microbiome and
metabolome have a role in precision nutrition. However, rigorously controlled feeding trials in humans are still
needed to determine the effects of whole diet inverventions on the microbiome and metabolome, and to test if
the microbiome and metabolome modify or mediate the effects of diet on cardiovascular risk factors, including
blood pressure. Of particular interest are the effects of dietary patterns and level of sodium (Na+) intake.
The primary objective of this study is to examine the effects of the American Heart Association recommended
Dietary Approaches to Stop Hypertension (DASH) diet (compared to a typical US diet) and lower dietary Na+
intake vs. higher dietary Na+ intake on the gut microbiome and the untargeted and targeted metabolome—
including short chain fatty acids—in a multi-racial cohort of adults with type 2 diabetes enrolled in the DASH4D
trial – a recently funded randomized, cross-over, controlled feeding trial. A secondary objective is to explore if
the gut microbiota and their metabolites modify and/or mediate the effects of diet patterns and sodium on blood
pressure, thusly informing precision nutrition. We will also examine if effects vary by sex and race. In particular,
we propose to perform whole genome shotgun metagenomics, high-throughput metabolomics profiling, and
targeted quantification of short chain fatty acid metabolites. We will jointly investigate the microbiome and
metabolome measured in stool and blood collected before and after each of the diet periods in the feeding trial.
Dr. Mueller (PI) will carry out this research with an outstanding group of interdisciplinary co-investigators in the
collaborative and eminent environments of the Johns Hopkins Welch Center for Prevention, Epidemiology and
Clinical Research and the Bloomberg School of Public Health. Dr. Mueller’s co-investigators have
complementary expertise in feeding trials (Appel), microbiome statistics (Zhao), metabolomics (Rebholz),
bioinformatics (Bittinger), and short chain fatty acids (Pluznick). With the support of Dr. Mueller’s research
team, he is well positioned to complete the proposed activities. The findings have great potential to: (a) identify
objective measures of adherence to the DASH diet and lower dietary Na+ intake; (b) reveal novel mechanisms
underlying the BP effects of dietary patterns and Na+ intake; (c) offer new disease prevention strategies and
therapeutic possibilities and; (d) inform use of the microbiome-metabolome nexus for precision nutrition.

Public health relevance
PROJECT NARRATIVE The proposed research aims to determine the effects of a whole-diet intervention (the Dietary Approaches to Stop Hypertension (DASH) diet vs. a typical U.S. diet) and lower vs. higher sodium intake on the gut microbiota, the ensemble of microorganisms living in our intestinal tract, and their metabolites (i.e. metabolome) in a randomized controlled feeding trial of racially diverse adults with type 2 diabetes. The study will also assess whether the gut microbiome and metabolome modify, or mediate, the effects of diet and sodiium on blood pressure, thusly helping to inform whether the microbiome can be leveraged for precision nutrition approaches to prevent cardiovascular disease.